Harnessing Nanoscale Presentation to Elucidate the Impact of Therapeutic Packaging on Innate Immunity

Nanomaterial delivery systems are critical in the packaging and delivery of immunostimulatory, immunoinhibitory,
or immunomodulatory cues, which range from small molecules to biologics. However, an underappreciated factor
in the delivery process is the interface of delivery systems with immune cells, which critically affects downstream
signal propagation. A challenge in designing effective delivery systems across varied patient populations is
elucidating how particular structures propagate distinct downstream functions. Understanding propagation due
to cargo presentation at the immune interface would enable the design of delivery systems that can be
programmed with specific biodistribution, uptake, and processing outcomes. Addressing this effectively requires
nanosystems with high molecular precision to fully evaluate interfacial interactions on a molecular level. This gap
is unsolved by current delivery systems, which are inherently polydisperse, heterogeneous, and lack molecular
precision; they are unable to molecularly tune cargo stoichiometry, placement, and orientation. Thus, the
structure-function relationships that have been obtained cannot reveal the intricacies of cargo packaging at the
nano-immune interface. The overall goal of this program is to develop synthetic oligonucleotide
nanostructures that molecularly program interfacial interactions at immune interfaces to uncover the
impact of molecular cargo packaging on immunomodulation. We will explore two focus areas: Area 1: How
does cargo component spacing modulate receptor interactions and affect propagation? Many nanomaterials
deliver cargo that binds with immune cell receptors and multivalent interactions can enhance responses.
However, precise control over avidity-based binding and an understanding of the molecular positioning
requirements for optimal binding kinetics is underexplored due to structural polydispersity. Using our molecular
and programmable oligonucleotide platform, we will explore these interactions and identify nanoscale features
(positioning, stoichiometry, cargo type) that drive effective cargo binding across multiple receptors and signal
propagation. Area 2: What is the role of anisotropy at the nano-immune interface? The anisometric nature of
biologics and their preferred alignment can be harnessed in therapeutic design to access elevated potencies.
However, programming this synthetically and molecularly with current delivery systems is a challenge. We will
molecularly package cargo anisotropically to elucidate preferential interactions with cell-surface receptors.
Holistically, this program will: 1) generate insights for how molecular component placement and anisotropy in
nanoscale delivery systems alter nano-immune interactions and propagate distinct immunity; 2) uncover
preferential receptor cooperation mediated by therapeutic co-delivery; and 3) reveal biophysical interactions at
the nano-immune interface. This work will pave the way for our ability to elevate immunotherapeutic potency for
various drugs (small molecules, biologics) against different diseases (cancer, autoimmunity, infectious disease).

Public health relevance
Nanomaterial delivery systems can elevate the delivery of immune-related cargo. However, their inherent polydispersity, heterogeneity, and lack of molecular precision muddle the ability to fully understand the interactions at the nano-immune interface that drive effective delivery, processing, and potency across diverse patient populations. This work will molecularly position immune-related cargo and elucidate design rules that can advance the potency broadly for immunotherapeutic delivery.